Improved early prognostic algorithm for hepatocellulcar carcinoma

PROJECT SUMMARY/ABSTRACT
This is an application for a Mentored Clinician Scientist Research Career Development Award.
The goal of the proposed project is to provide the candidate with advanced skills needed to
transition to an independent translational investigator with focus on accurate prognostic
biomarkers and development of a tailored treatment algorithm in HCC. To facilitate this long-term
career goal the candidate will examine multiple imaging, clinical and blood-based biomarkers,
and investigate the role of liquid biopsy in HCC progression in liver transplant-eligible patients.
The candidate proposes a comprehensive training plan, combining didactic instruction overseen
by her mentors, formal coursework, participation in applied training experiences with individual
mentors/advisors, and supervised performance of relevant laboratory techniques. The proposed
study will enroll HCC patients listed for liver transplantation and follow until the time of
transplantation or disease progression and death. She will identify the determinants contributing
to the disparate outcomes by including novel functional imaging, clinical risk factors and
circulating biomarkers including circulating tumor cells, immune cells and tumor DNA. This
application provides a more tailored approach to patient management in the limited time available,
to offer effective therapy to patients who are challenged with a lethal cancer and end-stage liver
disease. It would also improve liver transplant organ allocation, thus improving overall therapeutic
value for liver transplant recipients.

Public health relevance
PROJECT NARRATIVE The incidence of hepatocellular carcinoma (HCC) in the U.S. is increasing rapidly, faster than all but one solid cancer, but its prognosis remains dismal with a median survival less than one year. This project aims to investigate the use of blood, imaging, clinical biomarkers associated with rapid HCC progression and develop an accurate predictive algorithm for HCC prognosis. This will provide a more tailored approach to patient management and offer them effective therapy early.